Role of prolactin in adipocyte-breast cancer cell crosstalk

Project Summary/Abstract
There is a gap in our understanding of how hormone prolactin (PRL), secreted by adipocytes, and the
serine/threonine PAK1 connect to coordinately regulate progression of human breast cancer (BC) and
adipocyte-breast cancer cell crosstalk. The long-term goal of this research is to establish PAK1, activated by
adipocyte-secreted PRL, as a new diagnostic tool for the metastatic potential of BC cells and provide needed
insight into the underlying mechanisms. The overall objective of the current application is to establish an
experimental system to study effects of adipocyte-secreted PRL on breast cancer cells and adipocyte-breast
cancer cells crosstalk and further establish the mechanisms by which PRL-activated PAK1 contributes to
breast cancer. The central hypothesis is that that adipocyte-produced prolactin enhances invasiveness,
tumorigenicity and metastatic potential of breast cancer cells through activation of PAK1 kinase and pTyr-
PAK1 is a biomarker to predict metastatic potential of these breast cancer cells. The rational for the proposed
research is that breast adipocytes secret adipocytokines including PRL, which may influence breast tumor
behavior. PRL promotes JAK2 activation and tyrosyl phosphorylation of PAK1 in breast cancer cells. The
central hypothesis will be tested by pursuing the following specific aims: Specific Aim 1 will test our working
hypothesis that PAK1 activated by adipocyte-derived PRL enhances breast cancer cell invasiveness and cell
motility via Tec kinase and that adipocyte-breast cancer cells crosstalk induces secretion of MMP-11 by
adipocytes and MMP-1 by breast cancer cells. Specific Aim 2 will test our working hypothesis that PAK1
activated by adipocyte-derived PRL affects tumorigenicity and metastatic potential of breast cancer cells in vivo
and that pTyr-PAK1 can serve as a biomarker to predict breast tumor metastasis. Under the sub-aim,
characterized PAK1 phospho-specific antibodies will be used to evaluate metastatic potential of the cells at an
early stage of BC. This proposal is conceptually innovative because it is expected to vertically advance and
expand our understanding of how obesity through adipocyte-secreted PRL influences BC and the unique role
of PRL-activated PAK1 in this process. This proposal is technically innovative as well because it will employ
unique PAK1 phospho-specific antibodies. The proposed research is significant because the elucidation of
PRL/PAK1 mediated intracellular signaling pathways will enhance our understanding of the mechanisms
involved in regulation of BC and will lead to development of PAK1-based tools for BC diagnosis.

Public health relevance
Project Narrative The proposed research is relevant to public health because the discovery of a novel prolactin/PAK1-dependent mechanism is ultimately expected to increase understanding the influence of obesity on the tumor microenvironment in human breast cancer. The proposed research is relevant to NIH mission because it pertains to developing fundamental knowledge on a role and mechanism of action of adipocyte-secreted prolactin in regulating breast cancer, which directly impact human health.